Thrombin Cleavage of Osteopontin Suppresses Host-Anti-Tumor Immune Response in Cancer

Expression of osteopontin (OPN), a circulating matricellular protein with pleiotropic functions, is up-regulated in
inflammation and cancer. OPN has multiple functional domains and a thrombin cleavage site (at Arg168 in human
and Arg153 in mouse). Thrombin cleavage exposes a cryptic integrin-binding site for α4β1 and α9β1 integrins at
the new C-terminus, SVVYGLR. We have shown that Arg168 is a bona fide thrombin cleavage site, and thrombin-
cleaved OPN-Arg (OPN-R) has enhanced α4β1-dependent cell-binding activity which is abolished when the C-
terminal arginine is cleaved by carboxypeptidase N (CPN) or thrombin-activatable CPB2, converting it to OPN-
Leu (OPN-L). OPN-R and OPN-L levels are elevated in inflammatory joint fluid and cerebral spinal fluid in
glioblastoma (GBM), based on specific ELISAs developed in our lab, demonstrating that these cleavages occur
in vivo. OPN has been implicated in promoting invasive and metastatic progression of many cancers, including
breast, lung, prostate and ovarian cancers, GBM and melanoma. However, the role of thrombin cleavage of OPN
in cancer biology in vivo is undefined. We created a thrombin-resistant OPN knock-in (KI) mouse in which Arg153
is replaced by alanine (OPNR153A). OPNR153A KI mice are healthy and fertile. In preliminary studies, we showed:
1) decreased murine B16 melanoma growth and pulmonary metastasis in OPN KO and OPNR153A KI mice
compared to WT mice. 2) OPN KO and OPNR153A KI B16 tumors had significantly increased infiltrating F4/80+
macrophages. 3) Tumor suppression in the OPNR153A KI mice was abolished by macrophage depletion in vivo
and it was not observed in the immune deficient NOG-WT, NOG-OPN KO and NOG-OPNR153A KI mice. Thus,
tumor suppression in OPNR153A KI mice is mediated by F4/80+ macrophages. 4) Oral administration of dabigatran,
an orally active direct thrombin inhibitor, suppressed B16 tumor growth and metastasis in WT mice, replicating
the OPNR153A KI phenotype. 5) Malignant ascites was suppressed in OPNR153A KI mice in a murine ovarian cancer
model. Our overall hypothesis is that thrombin cleavage of OPN leads to suppression of the host-anti-tumor
immune response, associated with a decrease in tumor-associated macrophages (TAMs), thus favoring tumor
growth and metastasis. Blocking thrombin cleavage of OPN will lead to enhancement of the host-anti-tumor
response, resulting in reduced tumor growth and metastasis. Specific Aim 1 will determine if B16 tumor
suppression in the OPNR153A KI mouse is generalizable to other murine and human cancer models. We will test
the OPNR153A KI mouse in the murine ovarian cancer and GBM models (Subaim 1.1). We will reconstitute the
immune deficient NOG mice with human immune cells to create “humanized” NOG-OPN KO and NOG-OPNR153A
KI mice. We will validate the tumor suppression observed in the murine cancer models with the corresponding
human cancer models, and test additional human cancer models in these “humanized” mice. Specific Aim 2 will
test whether dabigatran functions as an adjunctive therapy with standard melanoma therapy. We will test whether
the OPNR153A KI mouse shows tumor suppression with murine YUMM3.1 melanoma cells carrying the BRAFV600E
mutation (Subaim 2.1). We will then test whether dabigatran, in combination with vemurafenib (BRAF kinase
inhibitor) or vemurafenib and cobimetinib (MEK kinase inhibitor), prolongs the survival of WT mice with
YUMM3.1/BRAFV600E melanoma (Subaims 2.2 and 2.3), and whether dabigatran adds to dacarbazine in the
survival of WT mice with B16 melanoma (Subaim 2.4). In Specific Aim 3, we will over-express OPN-R, OPN-L,
and OPN-CTF (C-terminal fragment) in the OPN-KO and OPNR153A mice to determine which cleaved OPN form
reverses the B16 tumor suppression phenotype (Subaim 3.1). We will characterize TAMs from B16 tumors in
OPN KO and OPNR153A KI mice and compare them to that from WT B16 tumors (Subaim 3.2). We hypothesize
that thrombin cleavage of OPN in WT mice reduces TAM infiltration and induces a “tumor promoting” M2-like
phenotype, whereas TAMs in the OPN KO and OPNR153A mice will have a proinflammatory “tumor suppressing”
M1-like phenotype. Our observations are novel, significant and relevant to cancer research and clinical practice.

Public health relevance
Cancer is a major health issue in Veterans. Osteopontin (OPN) is a protein implicated in many cancers including lung, colon and prostate cancers, glioblastoma (brain cancer) and melanoma (skin cancer). Thrombin, the key blood clotting enzyme, cuts OPN at a specific site, giving rise to two OPN fragments with new functions not seen in intact OPN. We created a knock-in mouse in which normal OPN is replaced by one that is resistant to thrombin cutting. We showed that mouse melanoma growth and spreading are suppressed in these animals. Dabigatran (Pradaxa), an oral anticoagulant widely used in clinical practice, inhibits thrombin and replicates the melanoma suppression in normal mice. We will test whether this observation can be generalized to other mouse and human cancers, and whether dabigatran is an effective adjunct to standard melanoma therapy. We will study the mechanism(s) involved. Blocking OPN cutting by thrombin, either by dabigatran or some other means, may become a new therapeutic modality in the treatment of many cancers commonly encountered in our Veterans.